HIV+ Service delivery and Telemedicine through Effective PROs

PROJECT SUMMARY
Patient-reported Outcomes (PROs) have been integrated into routine care at the UAB HIV Clinic to
monitor depression and substance use disorders (SUD) that, when untreated, threaten progress along the HIV
care continuum. PROs more accurately identify these comorbid conditions relative to provider documentation.
Thus, PROs enable clinics to allocate scarce mental health (MH) and SUD services to those in greatest need.
Additional treatment barriers remain even for patients with prompt diagnoses, especially in rural and Southern
states with limited access to MH and addiction treatment providers. Telemedicine has been effectively used to
expand medical care to rural and impoverished areas. Yet, there remains a knowledge gap about optimal
implementation strategies for and effectiveness of innovative technologies (PROs, telemedicine) in real-world
settings. To address this gap, investigators will leverage the Alabama Quality Management Group (AQMG), a
consortium of Ryan White HIV/AIDS Program (RWHAP)-funded clinics in Alabama, founded in 2006. We
propose a multicomponent intervention, HIV+ Service delivery and Telemedicine through Effective PROs
(+STEP), to increase screening and treatment of depression and SUD in AQMG sites. According to Gelberg’s
Behavioral Model for Vulnerable Populations, health outcomes are optimized by addressing (1) predisposing
factors like MH and substance use disorders; (2) enabling factors such as personal and community resources;
and (3) health behaviors like use of medical services. The +STEP intervention will address these domains using
PROs to more accurately diagnose depression and SUD (predisposing), targeted knowledge to frontline
clinicians (enabling), and use of telemedicine to expand MH and SUD resources (health behavior). We propose
a hybrid type 1-design study to evaluate the implementation and effectiveness of this multicomponent
intervention (PROs, training, and telemedicine). We will use the Consolidated Framework for Implementation
Research (CFIR) to identify implementation strategies and guide implementation, scale up, and maintenance of
+STEP. Our principle objectives are to characterize patient and clinic uptake; create an implementation blueprint
of barriers, facilitators and implementation strategies; and evaluate effectiveness through the following aims:
Aim 1. Conduct a needs assessment and implement +STEP to improve diagnosis and treatment of MH and SUD
at 6 RWHAP clinics in Alabama.
Aim 2. Describe implementation strategies addressing barriers to uptake of +STEP in six RWHAP clinics using
CFIR.
AIM 3. Measure the impact of implementing +STEP on diagnoses, referrals, and healthcare utilization related to
depression, SUD, and HIV by comparing clinical outcomes from patients receiving +STEP with historical controls.
The expected outcomes are an implementation blueprint and real-world outcomes to inform broad
implementation of +STEP to accelerate progress along the HIV continuum towards ending the HIV Epidemic.

Public health relevance
Narrative Depression and substance use disorders (SUD) in persons living with HIV (PLWH), when untreated, threaten HIV care continuum outcomes such as engagement in care and treatment adherence. HIV, mental health (MH), and SUD, disproportionately affect rural and Southern states due to proximity to medical care and a lack of mental health and addiction providers. Through enhanced screening (patient-reported outcomes) and linkage to expanded treatment options (telemedicine), this proposal will optimize care of depression and SUD, a critical step towards ending the HIV Epidemic.